Administrative Core

PROJECT SUMMARY – Administrative Core
This Program Project renewal, “Advancing Equitable Risk-based Breast Cancer Screening and Surveillance in Community Practice,” is a complex undertaking involving three research Projects, three Cores, seven breast imaging registries that will collect new data from 116 participating imaging facilities and images from 30 facilities, a Statistical Coordinating Center, and multiple committees – all must work closely together seamlessly to ensure success. The Administrative Core will be the operational backbone of the Program, assisting the Projects and Cores in achieving their aims, and facilitating a collaborative environment to ensure that the Program functions efficiently and productively. The Breast Cancer Surveillance Consortium (BCSC) has developed an effective model for Program management and integration, demonstrated by the success and productivity of the current Program upon which this renewal builds. The Administrative Core team will continue to use this organizational model based on principles of team science to centralize coordination, communication, and integration among the Projects and Cores. Activities will include providing overall scientific leadership, fiscal oversight, and administrative support by setting timelines and milestones, planning virtual and in-person program meetings, and overseeing Project and Core budgets and deliverables. The Administrative Core will standardize and facilitate inter-Project collaboration by maintaining and monitoring established policies and procedures that ensure fairness and authorship opportunities for all investigators. The Core will assess Program performance through an annual evaluation, and develop and implement improvement plans to overcome any challenges. The Core will continue to support effective communication strategies for disseminating research findings and mechanisms to encourage and facilitate data sharing with external investigators. The Administrative Core specific aims are: Aim 1) Maintain centralized coordination of the Program’s logistical and financial requirements; and Aim 2) Provide integrative support to Projects and Cores by promoting collaborations to create synergy within the Program. Together, with integration and support from the Administrative Core, the Projects and Cores will efficiently achieve multiple, related research goals united by a common theme by sharing methods, data, and results. The BCSC has 25 years of experience in collaborative, multi-site research, including 9 successful years under this P01 mechanism. With our team’s experience in breast cancer research, leadership, multisite collaboration, data sharing, and overall research program coordination, we are well-positioned to continue providing all necessary management and integration to continue and extend this Program’s success.

Public health relevance
PROJECT NARRATIVE – Administrative Core The Administrative Core will coordinate the organizational, scientific, and fiscal management of our Program Project to support the individual Projects and Cores. Our Program administration is grounded in principles of team science including trust and accountability, a shared vision, open communication, defined roles and responsibilities, and proactive conflict management. Through the Program’s established shared governance operationalized through effective communication and efficient coordination, the Administrative Core will enhance synergy across the Program.